Evaluating Whether Treating Elevated Blood Pressure in the Inpatient Setting Impacts Patient Outcomes: the ACT-BP pilot

Project Summary
Approximately 50-72% of the 36.2 million individuals admitted to U.S. hospitals are diagnosed with
hypertension. Hypertension increases the risk of devastating cardiovascular outcomes, such as strokes, heart
attacks, and heart failure. Three-quarters of admitted patients experience at least one elevated blood pressure
(BP) (>140/90) during hospitalization. While BP is usually elevated for benign reasons, including pain and
anxiety, acutely elevated BP can cause end-organ damage. Currently, no guidelines exist for managing
asymptomatically elevated BP in the inpatient setting. There is growing observational evidence that
antihypertensive medication intensification for asymptomatically elevated BP can result in adverse outcomes,
such as increased readmission. Since observational studies are biased, a large-scale clinical trial is needed to
identify whether to treat asymptomatically elevated BPs in the hospital. Yet, it would be unethical and costly to
randomize individual patients to receive antihypertensive medication intensification. To overcome these
obstacles, we designed ACT-BP, a hospital-unit-level intervention. ACT-BP removes standing orders to call
physicians about elevated BPs (which encourages treatment due to social desirability bias), provides education
on the potential harm of treating asymptomatically elevated BPs, and suggests alternative procedures (e.g.,
monitoring BP more frequently). If funded, we will obtain three specific pieces of knowledge needed to conduct
a larger, adequately powered randomized clinical trial: 1) how much does ACT-BP reduce antihypertensive
medication intensification; 2) what refinements will improve its effectiveness; 3) what is the rate of the
composite outcome in the intervention and control units. At the end of the funding period, we will know whether
it is feasible to persuade clinicians to reduce antihypertensive medication intensification for asymptomatically
elevated BPs in the hospital setting. This information would ensure that our future cluster-randomized trial can
test the efficacy of antihypertensive intensification on our composite outcome. Thus, it is scientifically
necessary to prove we can change intensification patterns. Then, our future RCT will be the first to provide
rigorous evidence on whether intensifying antihypertensive medications to address asymptomatically elevated
BPs increases the risk of new onset stroke, acute kidney injury, or myocardial infarction. In sum, this R34 grant
will provide the scientific knowledge to understand whether a medical unit-level intervention is effective in
changing antihypertensive intensification patterns in preparation for the larger R01-funded clinical trial that
would establish the safety and efficacy of reducing the use of antihypertensives for patients with
asymptomatically elevated BP.

Public health relevance
Project Narrative The vast majority of the 36.2 million individuals admitted to U.S. hospitals are diagnosed with hypertension and experience an elevated blood pressure (BP) reading during hospitalization. There are no guidelines for managing asymptomatically elevated BPs in the inpatient setting, and growing observational evidence suggests that antihypertensive medication intensification increases harm. The proposed study tests whether a unit-based intervention (ACT-BP) can reduce antihypertensive medication intensification and provides information that is scientifically necessary for designing a cluster-randomized clinical trial that identifies the impact of intensification after experiencing an asymptomatically elevated BP on patient outcomes.